Mechanisms of Phthalate Toxicity in the Ovary

PROJECT SUMMARY/ABSTRACT
This K99/R00 award will prepare Dr. Genoa Warner for an independent research career, with the main goal of
providing Dr. Warner with all the technical and profession skills necessary for her to become a successful
independent investigator and leader in the field of reproductive toxicology. Dr. Warner has extensive training in
endocrine disruption and sustainable chemistry and is currently a postdoctoral fellow in reproductive toxicology
at the University of Illinois under the mentorship of Dr. Jodi A. Flaws. This award will enable Dr. Warner to expand
her research training in reproductive biology and allow her to draw from her diverse scientific background in
chemistry and biology to investigate important research questions in environmental health. These goals will be
accomplished with the support of Dr. Warner's exceptional mentoring team, composed of Dr. Flaws, Dr. Susan
Schantz, Dr. Heather Stapleton, and Dr. John Katzenellenbogen. The research proposal and career
development plan created by Dr. Warner with the guidance of her mentoring team will provide Dr. Warner with
new experimental techniques and skills needed to establish an independent research program. In the research
training component of this proposal, Dr. Warner will investigate the mechanisms by which phthalates, a group of
endocrine disrupting chemicals with ubiquitous human exposure, cause ovarian follicle toxicity. Further, she will
investigate the metabolism of phthalates by ovarian tissue because phthalate metabolites mediate phthalate-
inducted toxic effects, contributing to infertility and premature ovarian failure. In the prosed studies, Dr. Warner
will use environmentally relevant concentrations of six phthalates as a mixture and individually. Specific Aim 1
(mentored phase) will identify how phthalates partition into ovarian tissue during culture via mass spectrometry
and imaging methods using chemically modified phthalates. Specific Aim 2 (mentored and independent phases)
will determine how phthalate toxicity varies between cell types of the ovary by culturing populations of each cell
type found in the ovarian follicle with phthalates. Finally, Specific Aim 3 (Independent Phase) will identify the
genomic localization of phthalates in the ovary by adapting the biochemical technique of chemical affinity capture
paired with massively parallel DNA sequencing (Chem-seq) to provide information on the genes and proteins
targeted by phthalates. Overall, the proposed studies will provide novel chemical and mechanistic insight into
causes of phthalate-induced toxicity in the ovary that contribute to female infertility and premature ovarian failure.
The methods combine chemical and biological techniques to develop a new, widely applicable technology for
investigating the mechanisms of endocrine disrupting chemicals that will provide the basis for Dr. Warner's
independent career.

Public health relevance
PROJECT NARRATIVE Exposure to endocrine disrupting chemicals such as phthalates contributes to increased rates of human infertility and reproductive disorders worldwide. The proposed research will fill a public health need by developing a method to investigate the mechanisms through which endocrine disrupting chemicals such as phthalates act to cause toxicity in the ovary. The results of this project will facilitate the development of safer alternative chemicals and contribute to the identification of new treatments to protect the ovary from environmental chemical exposure.